Outreach, Dissemination, and Training Core

The Outreach, Dissemination and Training Core (Outreach Core) of the Indiana University-Ohio State
University Maternal and Pediatric Precision in Therapeutics Data, Model, Knowledge, and Research
Coordination Center (IU-OSU MPRINT DMKRCC) will serve as a conduit between the MPRINT Hub and the
broader scientific community. The Outreach Core will facilitate interactions with external partners to enhance
knowledge, research, and educational efforts in maternal and pediatric therapeutics. The aims of the Outreach
Core include: 1) Working in concert with other KRCC cores and the MPRINT CETs, develop a centralized
MPRINT Hub website and identity, coordinate timely dissemination of data through the MPRINT Hub and
promote, monitor, and evaluate utilization of the MPRINT Hub; 2) Promote the MPRINT Hub to researchers,
clinicians, and the public by organizing an annual MPRINT Hub scientific meeting, presentations at scientific
meetings, through publications, and over social media in order to expand maternal-pediatric clinical
pharmacology research and foster collaborations with public and private research partners; and 3) Develop,
disseminate, and conduct training opportunities for individuals within and beyond the MPRINT Hub to develop
skills in maternal and pediatric pharmacology, pharmacometrics, pharmacogenomics, data science, and drug
development. Such opportunities will include workshops at scientific meetings and the annual MPRINT Hub
scientific meeting, webinars and online tutorials, which will be made freely available through the MPRINT Hub
website and the NICHD’s Virtual Network for pharmacology trainees. The Outreach Core will also survey the
community to help identify gaps in knowledge and research tools as well as the success of the MPRINT Hub to
satisfy the needs of the maternal and pediatric therapeutic research community. Additionally, the Outreach
Core will maintain and evaluate usage of the MPRINT Hub Website and social media platforms, and
coordinate with the MPRINT Hub Steering Committee to reprioritize activities and set milestones for
performance. Through these activities, the Outreach Core will promote the resources provided by the MPRINT
Hub in order to accelerate research in maternal and pediatric therapeutics.